Inflammasome-modulating Polymeric Biomaterials to Augment Tissue Repair

SUMMARY
Wounds are a major national and global health burden with an annual incidence of more than 6 million cases
of chronic skin wounds collectively costing more than $20 billion per year in the USA. Common comorbidities
such as diabetes, burns and infection impair healing and increase morbidity and mortality. The biochemical
hostility and sub-optimal vascularization in the injured tissue microenvironment combined with the multiphasic
biological mechanisms of tissue repair, which are dysregulated in the diabetic host, limit the efficacy of
therapeutic treatments. There is an urgent need for novel, engineered biomaterials to facilitate the temporal
delivery of bioactives to augment and promote the effective resolution of intractable wounds. Silk fibroin (SF)
and chitosan (CS) are biopolymers that can be specifically and systematically tuned to optimize key properties
including loading capacity, release kinetics, biocompatibility, degradability and mechanical strength for effective
drug delivery. This proposal will develop a biomaterial platform for temporally controlled sustained release of
immunomodulating small molecules and growth factor nanoparticles to augment tissue repair. Aim 1 will focus
on the development and characterization of a platform of unmodified and derivatized SF, CS and blend SF-CS
scaffolds to deliver small molecule modulators of the inflammasome pathway and will test the platform in a
relevant mouse model of impaired tissue injury. Aim 2 will focus on the combinatorial delivery of growth factor
nanoparticles and small molecule drugs with distinct temporal release kinetics to further augment the efficacy
and quality of tissue repair. The success of the research and career development plan in this K01 proposal is
supported by a strong, diverse mentor team with complementary scientific expertise in drug delivery, growth
factor nanoparticles, dermatopathology and immunobiology and substantial experience in advising early stage
investigators. Dr. Yaron (PI) is an assistant research professor with a strong background in inflammation
biology, immune modulation and tissue repair and the primary mentor, Dr. Rege, is an expert in biomaterials
innovation for tissue repair. Dr. Yaron will receive training in the Design-Build-Test biomaterials development
principles and bioengineering methods necessary to develop an independent research program on
translational immunomodulation technologies for tissue repair. This proposal leverages the innovative,
scientifically robust environment at Arizona State University to develop a novel biomaterial platform for the
controlled delivery of small molecules and biological nanoparticles for therapeutically augmenting tissue repair,
with a strong path to clinical translation.

Public health relevance
PROJECT NARRATIVE Novel, engineered biomaterials that facilitate temporal delivery of bioactives are urgently necessary for effective resolution of intractable wounds complicated by comorbidities such as diabetes, burns, and infection. Biopolymers such as silk fibroin and chitosan provide a facile toolkit to develop sustained release drug delivery platforms to deliver small molecules and therapeutic proteins. The overall goals of this research are 1) to develop and characterize a sustained release drug delivery platform using composite blend and bilayer silk fibroin and chitosan scaffolds to deliver small molecule immune modulators and growth factor nanoparticles, and 2) to evaluate the efficacy of the platform in a relevant small animal model of impaired tissue repair which will establish a strong clinical translation path for a new approach to treat intractable wounds.